Administrative Core

ADMINISTRATIVE CORE PROJECT SUMMARY
COBRE Phases I and II supported eight early-career Project Leaders and one mid-career Project Leader. Six
Project Leaders graduated with major independent grant support and the most recent COBRE recruit, Dr. Prayag
Murawala, has achieved significant professional success and is on a strong path to independent R01 support.
Past and current COBRE Project Leaders have achieved multiple professional milestones in publications, grants,
patents, new disease models and research tools, as well as the formation of an IDeA program/Maine state
government partnership that allowed MDIBL to obtain $3M in voter-approved state bond funding to expand
research infrastructure. COBRE Phase III will continue to build the research infrastructure of the Davis Center
by establishing self-sustaining core facilities and funding pilot programs in Aging and Regeneration research.
COBRE Phase III will greatly enhance the development of the Davis Center and MDIBL, which in turn will
contribute to the continued enhancement of the biomedical research environment in Maine.
The Administrative Core is critical to the management and success of COBRE Phase III. The COBRE PD/PI and
Administrative Core Director, Dr. Iain Drummond, has primary responsibility for administering the program and
overseeing the continued development of the COBRE cores and pilot project program. He is assisted by the
Program Coordinator, Amy Ackerman. Decisions regarding budgets, core usage and direction of the COBRE
Pilot program are made by the Director with advice from the Advisory Committee (AC). Leadership and oversight
include establishing and managing the allocation of all Center resources; maximizing the impact and reach of
core services, consolidating budgetary systems to ensure core sustainability, organizing Center activities;
organizing AC meetings; continued professional development of past COBRE project leaders and MDIBL faculty;
evaluation and prioritization of Pilot project funding, and interactions with other groups to further COBRE goals.
MDIBL’s long-term strategic scientific goal is to build a world-class research program in aging and regenerative
biology. The Davis Center will remain MDIBL’s sole research focus for the foreseeable future and sustainability
of its scientific programs is therefore of the highest priority to MDIBL leadership. Sustainability will be achieved
by providing cutting edge core services and continuing to grow the COBRE network with innovative pilot project
funding and access to breakthrough technologies.